A distributed and interdisciplinary pipeline for sustainable student-driven innovation

Felder et al_R25_2022_Abstract_FINAL
Modern engineers need to blend technical competence with global and competitive competence.
For biomedical engineers, efforts to support these core competencies is to cultivate the ability to
translate and commercialize design and innovation to impact the end-users. To meet this goal,
we propose to establish a distributed and interdisciplinary pipeline for sustainable student-driven
innovation. This proposal encompasses a comprehensive curriculum across disciplines to drive
longitudinal project development and innovation. Our first specific aim is to enhance senior
design project preparedness and student competency. This aim is met by thoroughly validating
needs with a redesigned interdisciplinary clinical immersion program and by developing a new
undergraduate biomedical engineering course to enhance student physical prototyping skills.
Needs fully validated by biomedical engineering and Innovation Medicine program medical
students with primary clinical experience ensures project development is aligned with the ability
to commercialize a product, and enhanced student prototyping skills support realistic
development with enhanced fidelity. Together these initiatives enable our second specific aim,
which is to leverage interdisciplinary collaboration to enhance medtech device design. This aim
is met by revising the undergraduate biomedical engineering senior design capstone to
incorporate the same medical students from clinical immersion. Moreover, the senior design
class will accept projects based on validated needs from clinical immersion, which enables
accelerated pacing and inclusion of both verification and validation in class. Product
development from senior design is then transitioned for further development to the same medical
students with their own capstone experience. Continuing projects from clinical immersion to
senior design and then to medical capstone has substantial benefit including the ability to retain
technical development and pursuit of further development that was not otherwise possible (e.g.,
publication of development, execution of limited studies, pursuit of intellectual property) by one
capstone experience alone. Effects of clinical immersion to validate needs and the prototyping
class to enhance prototyping competency will be evaluated using surveys and deliverables.
Effects of project origin (i.e., clinical immersion or other) and participation in the prototyping
class will be evaluated on the ability of teams to effectively collaborate within and outside
disciplines, design, verify performance requirements, and validate that design output meets
original need. Long-term success of leveraging interdisciplinary collaboration for medtech
device design will be evaluated by comparative assessment of medical capstone deliverables
based on project origin and participation of the pipeline. This proposed pipeline has the potential
to enable significant student-driven innovation.
1

Public health relevance
Felder et al_R25_2022_Project_Narrative_FINAL Today’s undergraduate biomedical engineering students require training to translate and commercialize design innovations to impact society. Here, we introduce a project development pipeline for distributed, interdisciplinary, and sustainable student-driven innovation. The goal of this proposal is to enhance biomedical engineering student education and facilitate longitudinal project development through interdisciplinary collaboration. 1